Advancing Understanding of Genomic Mechanisms for Primary ADHD in Families

ABSTRACT
The genetic mechanisms contributing to neurodevelopmental disorders are highly variable across children
and families. This is especially true for attention-deficit/hyperactivity disorder (ADHD), which affects
approximately 7% of school aged children. In the last decade, databases containing genomic information about
individuals and families with ADHD have been developed. However, the individuals within these databases are
highly heterogeneous, due to varying recruitment methods, ADHD diagnosis, and variable inclusion/exclusion
criteria. For example, some individuals with ADHD may have comorbid autism (ASD) or intellectual disability
(ID), and many individuals self-report their ADHD status, without a standardized approach to confirming the
diagnosis. As a result, much of the underlying genetic etiology of well-defined primary ADHD (i.e., ADHD without
comorbid ID or ASD) remains unknown. Common variants account for a minority of variance in ADHD, and our
pilot data suggests that up to 50% of individuals with primary ADHD have a rare pathogenic variant accounting
for their diagnosis.
We aim to improve the understanding of the genetic underpinning of primary ADHD through the following
major goals: 1) Developing the largest family-based repository of children with primary ADHD and their family
members using consistent, precise, and comprehensive diagnostic criteria, as well as standardized evaluations
of parental and sibling ADHD status. 2) Identify novel candidate genes for ADHD and expand on previous studies
that have focused on de novo (spontaneous) genetic mutations, by also examining co-segregation of ADHD and
inherited genetic variants, thereby providing the most comprehensive analysis of the genomic architecture of
ADHD to date. 3) Validate our gene discovery by assessing genome-wide significance in an existing sample of
5,595 cases and 62,739 healthy controls. 4) Develop a more robust clinical variant classification approach
through integrated family histories and functional studies that will increase understanding of the impact of
variants of unknown significance and will provide a valuable resource for future genomic and
neurobiological functional studies.
To do this, we will analyze genomic data from 1,400 children and their families who have been diagnosed
with ADHD (without autism or intellectual disability) using comprehensive neuropsychological evaluation from
two sources: 402 from our own Developmental Medicine Center (DMC) at Boston Children's Hospital, including
187 already recruited; and 998 from the IMAGE Study, for which data is available through the NIH RGR. We will
validate our findings in a sample of 5,595 cases and 62,739 controls from the NIH All of Us Research Program.
We will conduct whole exome sequencing (WES) on all participants, perform mRNA-sequencing from hiPSC-
derived neural cells to clarify the impact of a subset of variants of unknown significance, and perform patient-
and CRISPR-derived iPSC analyses on a subset of 5 damaging variants of interest.

Public health relevance
PROJECT NARRATIVE Heterogeneity in attention-deficit/hyperactivity disorder (ADHD) diagnoses and among existing genomic studies poses a major challenge that has left much of the underlying genetic etiology of well-defined primary ADHD (i.e., ADHD without co-occurring intellectual disability or autism spectrum disorder) unknown. The proposed study will be the first to assess the genetic architecture of ADHD through the development a large cohort of children with primary ADHD and their families using consistent, precise, and comprehensive diagnostic criteria. Findings from our family-based study will improve our understanding of genomic architecture of ADHD, provide important genetic diagnoses for families, and inform future genomic and neurobiological functional studies that are likely to impact clinical management for families with ADHD.